Research Project Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Research Project Core (Core B)
The goal of the research project core is to support cutting edge new research projects on the economics of
ADRD prevention, treatment, and care. As funding resources allow, we anticipate providing 5-8 one-year awards
annually. In a cooperative agreement with NIA, we will lay out a thematic architecture for the projects that
identifies and prioritizes key research themes. The initially prioritized themes are: (1) Emerging Challenges in
Caregiving for People with ADRD, (2) Understanding ADRD Diagnosis and Progression, (3) Prevention and
Treatment of ADRD, and (4) Disparities in Healthcare for Patients with ADRD. The NBER will advertise the
availability of these research awards in a widely distributed call for applications, detailing the prioritized research
themes. Once the project proposals have been submitted, the core will administer a scientific peer review
process to score and prioritize submissions, and to select each year's new projects. Projects will be selected
based on the reviewers' evaluation of the research plan, its relevance to the priority themes of the consortium,
and its potential to make an important scientific contribution to our understanding of the economics of
dementia/AD.